Southern California Clinical and Translational Science Institute

Contact PD/PI: Buchanan, Thomas A
OVERALL COMPONENT
Project Summary/Abstract
The Southern California Clinical and Translational Science Institute (SC CTSI) is submitting this revision for a
third cycle of Clinical and Translational Science Award (CTSA) funding at a time of dramatic growth and
opportunity at our hub. The SC CTSI encompasses the University of Southern California (USC) and Children's
Hospital of Los Angeles (CHLA), in close partnership with the Los Angeles County Department of Health
Services. Our vision is to be a leader in clinical and translational research to benefit diverse communities and
special populations. Our approach builds on past success, acknowledging the changing landscape of clinical
and translational research (CTR), the priorities of the CTSA program, and the evolving needs of our
researchers, trainees, patients and communities. Our scope leverages strengths in clinical, health system, and
community research, education and training, within two overarching themes: diversity and impact. Diversity is
reflected in the communities, health systems, and scientific disciplines we engage to improve health care and
outcomes. Impact encompasses academic productivity as well as benefit to our workforce, health systems,
patients, and communities. To pursue our vision in the context of our scope and themes, we propose six
specific aims: (1) Workforce Development: Train a highly skilled workforce with the knowledge, skills, and
attitudes to conduct rigorous and reproducible research focused on the evolving health needs of diverse
communities. (2) Collaboration and Engagement: Create a culture in which team-based research, engaging all
stakeholders and following sound principles of team science, is the standard approach to addressing complex
challenges in health and research. (3) Integration: Engage our diverse communities to establish clinical
research priorities; identify barriers to research; and develop, demonstrate and disseminate innovative
approaches to assure fully partnered clinical research across communities and the lifespan. (4) Methods and
Process: Apply principles of quality and process improvement to clinical and translational research to develop
and share novel approaches to enhance efficiency, quality and impact. (5) Informatics: Provide an agile
information ecosystem that encompasses research, clinical care, communities and their environment, providing
a holistic view of health and disease and serving as the engine for discovery, innovation and insight. (6) CTSA
Hub: Participate in CTSA network activities, conduct multi-site studies, adopt successful models from peers,
and develop, demonstrate and disseminate innovative approaches. Achieving these aims will advance the
discipline of CTR directed at improving health in diverse and underserved communities.
Glossary
ACT – CTSA Program Accrual to Clinical Trials Network IRB – Institutional Review Board
BERD – Biostatistics, Epidemiology, Research Design core group ISI – USC Information Sciences Institute
CD2H – CTSA Program National Center for Data to Health IT – Information Technology
CE – Community Engagement core group KSOM – Keck School of Medicine of USC
CEREC – CTSA External Reviewer Exchange Consortium LA – Los Angeles
CHDP – Community Health Demonstration Projects LAC DHS – LA County Department of Health Services
CHLA – Children's Hospital Los Angeles LGBTQ+ – Lesbian, Gay, Bisexual, Transgender, Questioning
CLIC – CTSA Center for Leading Innovation and Collaboration MRC – Mentor Resource Center
CLS – Community Listening Session N3C – National COVID Cohort Collaborative
CRI – Clinical Research Informatics core group NGHP – Nickerson Gardens Housing Project
CSU – Colorado State University NIH – National Institutes of Health
CSULA – California State University Los Angeles NLP – Natural Language Processing
CTR – Clinical and Translational Research OC/OH-LA – Our Community/Our Health Los Angeles
CTTI – Clinical Trials Transformation Initiative PBRN – Practice-Based Research Network
DIAMOND – Development, Implementation, and Assessment of
Novel Training in Domain-based Competencies Portal QbD – Quality by Design
EAC – External Advisory Committee
SC CTSI – Southern California Clinical and Translational
Science Institute
EDWAP – Enterprise Data Warehouse and Analytics Platform SEDoH – Social and Environmental Determinants of Health
EHR – Electronic Health Record SNA – Social Network Analysis
ERC – Education Resource Center SSI – USC Spatial Sciences Institute
FHIR – Fast Healthcare Interoperability Resources
STELLAR – Self Career Training Education Lifelong Learning
Advancement Resource, a collaboration with Georgia CTSA
HACLA – Housing Authority of the City of Los Angeles TBV – Team Building Voucher
HDS – Healthcare Delivery Science TIN – Trial Innovation Network
HHS – Hollywood, Health & Society TS – Team Science
I2b2 – Informatics for Integrating Biology & the Bedside UCLA – University of California Los Angeles
ICD – Institutional Career Development URM – Under-Represented in Medicine
IIT – Investigator-Initiated Trial USC – University of Southern California
IOB – Internal Oversight Board WD – Workforce Development core group
Project Summary/Abstract Page 207
Contact PD/PI: Buchanan, Thomas A
UL1

Public health relevance
PROJECT NARRATIVE This application requests support from NIH for the Southern California Clinical and Translational Science Institute (SC CTSI), a multi-disciplinary institute housed at the University of Southern California and Children's Hospital Los Angeles. In partnership with the Los Angeles County Department of Health Services and broad based community health organizations in Los Angeles, the SC CTSI seeks to develop and support multidisciplinary clinical and translational research that will improve the health and address challenges in the conduct of clinical research, with particular focus on diverse, high disparity communities. Project Narrative Page 208